Graduate Training Program in Comparative Medicine

PROJECT SUMMARY
Ongoing support is requested for a “Graduate Program in Comparative Medicine” in the College of Veterinary
Medicine at Cornell University. Six post-doctoral positions are requested to provide training to DVMs seeking a
PhD. The Comparative Medicine Program combines the very best that Cornell offers in the form of didactic
graduate-level instruction, faculty supervision and training related activities. Trainees can follow one of two
tracks: one is geared to a career in basic research and one to a career in translational science. In each case,
training is structured to ensure the orderly progression of scholars to independence. Research areas available
to trainees are broad and include infectious disease, immunology, epidemiology, cancer biology, cell biology
and signal transduction, genomics and genetics, developmental biology, molecular medicine, and
neuroscience.
The proposed program combines independent, faculty-guided research with formal didactic instruction in cell
and molecular biology, genomics, and biostatistics, career counseling, and a variety of professional enrichment
activities calculated to develop the trainees' critical capacity, communication and teamwork skills. Graduate
scholars would earn the PhD degree. The average time to degree for veterinarians seeking a PhD at Cornell
University is 4.3 years; however, funding is requested for three years. The first six to nine months of training
support will be provided by Graduate Research Assistantships provided by the College of Veterinary Medicine
at Cornell. It is expected that trainees will apply for individual fellowships (“K” awards or equivalent) that would
support the trainee as they finish their graduate studies and transition to independent careers. However, all
trainers are selected with the goal of ensuring training support continues independent of any fellowship award.
Program alumni are encouraged to undertake at least two years of research beyond their PhD degree
preferably in a related discipline and at a different institution before accepting their initial appointment as an
independent investigator. Many alumni are expected to realize careers as faculty members in U.S. veterinary
colleges or medical schools, although some may seek research positions in independent institutions,
government, or industry. The goal of the program is to train veterinary scientists that can meet the national
need for trained veterinarians within academia, industry, public health, and government to address problems
relating to animal and human health.

Public health relevance
PROJECT NARRATIVE The Comparative Medicine Program at Cornell University is preparing accomplished and highly motivated veterinarians for discovery-based and public health careers in basic and translational science. By virtue of their broad knowledge of comparative disease and strong intellectual and lateral thinking abilities, veterinarians with advanced scientific training are expected to play an essential role in biomedical science and public health and to promote the NIH goal of developing, maintaining, and renewing scientific human resources that will ensure the Nation's capability to prevent disease.